Endoplasmic Reticulum-to-Mitochondria Calcium Transfer in Pancreatic Cancer Development, Metastasis, and Treatment

Pancreatic adenocarcinoma (PDAC) is a particularly lethal form of cancer that kills over 40,000 Americans
every year. PDAC is most often diagnosed when disease is advanced, with metastases that lead to death.
Patient outcomes are further negatively-impacted by a typical poor response to currently-available treatments.
It is thus critical to develop a stronger understanding of the processes which lead to PDAC development and
metastasis, as well as to determine novel, more-efficacious targets for therapies. Low-level, constitutive
endoplasmic reticulum (ER)-to-mitochondria transfer of calcium is required for optimal bioenergetics and
cancer-cell survival. We hypothesize that this pathway contributes to pancreatic cancer development,
metastasis, and tumor maintenance, and may therefore present a viable anticancer target. The ER-localized
IP3R calcium-release ion channel and the mitochondrial calcium-uniporter ion channel, MCU, mediate calcium
transfer between the two organelles at membrane-contact sites. However, it has been impossible to target this
pathway in vivo because of the lack of selective, cell-permeable pharmacological agents against these ion
channels. We therefore propose to examine the role of ER-to-mitochondria calcium transfer in PDAC
development, metastasis, and tumor maintenance through the use of novel animal and cell-culture models. We
will genetically delete MCU during early development in a murine genetic-model of PDAC, the KPCY mouse, to
observe the role of this protein in tumor development. In addition, we will use tumor cells as well as genetically-
modified cells using Cre/lox and CRISPR/Cas9 systems, as well as patient-derived cell lines and the
established human PDAC cell line, Panc-1. We will assay proliferation, cellular bioenergetics, oxygen
consumption rates, and mitochondrial calcium homeostasis, using biochemical, cell biological and biophysical
approaches, including electrophysiology, live-cell imaging and fluorimetry, to define the role of ER-to-
mitochondria calcium transfer in these processes. To determine the role of MCU in metastasis, we will quantify
metastasis in the KPCY model using the sensitive YFP-reporter gene, and we will use an in vivo tail-vein
metastasis model with genetically-modified Panc-1 cells expressing luciferase in NOD/SCID mice, as well as in
vitro transwell-invasion and gel-degradation assays, and biochemical and morphological assessment of
metastasis-associated markers of epithelial-to-mesenchymal transition. To observe the role of ER-to-
mitochondria calcium transfer in tumor maintenance and thus its therapeutic potential for more advanced
disease, we will use an inducible CRISPR/Cas9 cell-culture model of murine PDAC in vitro and an in vivo
inducible orthotopic model to observe the effects of acute MCU ablation in already-growing tumors and cells as
a method to simulate profound pharmacological inhibition. These studies will elucidate the role of ER-to-
mitochondria calcium transfer in PDAC development, metastasis, and maintenance, and they may inform
future development of novel therapeutic targets in PDAC, potentially saving lives.

Public health relevance
Pancreatic ductal adenocarcinoma (PDAC) has a poor prognosis, with about 50,000 new cases and 45,000 deaths every year. Whereas new therapeutics have increased the overall survival rate of cancer patients in general, these improvements are rarely seen in PDAC, emphasizing the need for new therapeutic targets. Because endoplasmic reticulum-to-mitochondria transfer of calcium is required for cancer cell survival, we propose to use animal and cell-culture models to identify the role of this process in the development and metastasis in pancreatic cancer, anticipating that this may lead to treatments that significantly improve patient outcomes for this highly lethal disease.